PSYCHOPHYSICAL INVESTIGATION OF BINOCULAR SUPPRESSION

Stable binocular single vision gives way to alternating periods of monocular suppression when the two eyes view dissimilar monocular stimuli. This phenomenon, called binocular rivalry, discloses the existence of a potent inhibitory process within the central visual pathways, a process that may be related to the suppression of vision that often accompanies disorders of binocular vision such as strabismus. The PI has recently developed a neural theory of binocular rivalry that consists of seven propositions, some of which are based on existing psychophysical data and others which are more axiomatic in form. A major aim of the present proposal is to test various aspects of the theory. Experiments are grouped into six broad categories that focus on: (1) the relation of rivalry to fusion; (2) cooperative interactions between local suppression zones; (3) the distinction between stimulus suppressed and stimulus absent; (4) the dependence of depth of suppression on monocularly innervated neurons: (5) the role of top down influences on dominance vs suppression; and (6) the neural events that terminate a suppression phase. Results from these experiments, besides critically testing the theory, will set the stage for a more critical examination of the relation between rivalry suppression in normal observers and clinical suppression in people with histories of disordered binocular vision.